NITRIC OXIDE IN PATIENTS WITH PULMONARY HYPERTENSION

Pulmonary vasoreactivity is assessed in patients with pulmonary hypertension prior to starting long term vasodilator treatment. Nitric Oxide is being evaluated as an acute test in these patients.